NATIONAL SURVEY OF CHILD AND ADOLESCENT WELL-BEING (NSCAW) III

The National Survey of Child and Adolescent Well-Being (NSCAW) is a nationally representative, longitudinal survey of children and families who have been the subjects of investigation by Child Protective Services. There have been two cohorts of children enrolled in the survey, which makes available data drawn from first-hand reports from children, parents, and other caregivers, as well as reports from caseworkers, teachers, and data from administrative records. NSCAW examines child and family well-being outcomes in detail and seeks to relate those outcomes to experience with the child welfare system and to family characteristics, community environment, and other factors. In September 2015, the Office of Planning, Research and Evaluation in collaboration with the Children's Bureau awarded a contract to RTI International to carry out the third cohort of NSCAW (NSCAW III). An overarching goal of NSCAW III is to maintain the strengths of previous work, while: 1) better positioning the study to address the changing child welfare population, and 2) increasing the project's overall utility.